Patient-specific, high-sensitivity spectral CT for assessment of pancreatic cancer

Abstract.
The proposed project concentrates on technology developments to enable high sensitivity, bias-tolerant spectral
CT for accurate quantitation of iodine concentration. Spectral CT has the potential of providing true quantitative
information of tissue composition and provides an avenue for combined functional and structural imaging. High-
sensitivity spectral CT accommodates anatomical sites that are traditionally hard to image, and reliable meas-
urements of iodine perfusion allow additional quantitative measures such as tissue texture to aid diagnosis and
clinical decision making. In the case of pancreatic cancer, the complex tumor microenvironment and the conse-
quential poor perfusion characteristics lead to difficulty in diagnosis, staging, and treatment assessment. The
need for visualizing low-enhancing lesions and the benefit of extracting quantitative information directly from
image data strongly motivate a high-sensitivity imaging modality for reproducible iodine measurements. The
need for visualizing low-enhancing lesions and the benefit of extracting quantitative information directly from
image data strongly motivate a high-sensitivity imaging modality for reproducible iodine measurements. How-
ever, state-of-the-art spectral CT presents large quantitation bias, i.e., inaccuracies in measured iodine concen-
tration compared to the truth. We identify three major sources that contribute to quantitation bias: imaging system
(e.g., spectrum mismatch), post-processing (e.g., biased estimator), and patient (scatter, beam hardening). The
bias effect in current spectral CT cannot be fully eliminated by increasing radiation exposure, and has complex
dependencies on the imaging system, imaging techniques, patient habitus, and processing algorithms. This in-
accuracy is a major impediment to pancreatic cancer management and quantitative applications in general. The
overall goal of this proposal is to develop robust, high-sensitivity spectral CT solutions that will enhance sensi-
tivity and reduce variability in iodine quantitation, which in turn enables accurate, high-performance spectral
biomarkers for disease management. The following specific aims will be pursued: (1) to develop an end-to-end,
modular theoretical model for robust spectral CT design and optimization, (2) to develop bias-tolerant processing
pipeline, and (3) to implement and evaluate high performance, hybrid spectral CT solutions on an experimental
CT bench. Completion of the proposed efforts enables robust, high sensitivity spectral CT for improved tumor
detection and characterization through accurate, high performance spectral biomarkers. Vendor- and spectral
technology-independent outcomes of the proposal include: optimized, patient-specific protocols; post-processing
pipelines that are robust against quantitative bias and variability; and the next generation spectral CT system
designs for enhanced iodine quantitation. Achievements from the proposed project will improve sensitivity and
quantitation accuracy of iodinated contrast media in spectral CT which enables quantitative diagnostics and
treatment assessment using robust iodine biomarkers across a broad range of clinical applications.

Public health relevance
Public Health Relevance. Diagnosis, staging, and treatment assessment of pancreatic cancer is severely challenged by the difficulty to delineate and reproducibly measure pancreatic lesions as a result of low-enhancement from contrast agents. We propose to develop high-sensitivity, low-bias spectral CT technology to enhance low concentration iodine visualization and mitigate system-dependent variability to allow quantitative image biomarkers as additional in- dicators for diagnosis and treatment efficacy. The technology developed in this work can be widely applied to improve quantitative accuracy of spectral CT applications, and facilitate robust clinical translation of novel spec- tral biomarkers for general disease management.